Discovery and characterization of bacterial cell envelope assembly and remodeling networks that modulate tolerance to antibiotics

Abstract
The bacterial cell envelope is a complex and dynamic multilayered structure essential for cell growth and division.
The structural layer of the envelope, known as the cell wall or peptidoglycan (PG), determines cell shape and is
essential for survival because it protects bacteria from osmotic lysis. The action of PG synthases, which add new
material for the enlargement of the cell wall, and PG hydrolases, which create space for expansion of the PG
mesh-like structure, are both necessary for growth. Some of our most powerful and successful antibiotics target
PG synthases and derive their efficacy from not only inhibiting cell wall assembly, but also by causing cell lysis
through the active destruction of the cell wall by PG hydrolases. Because of their potential to cause cell lysis, it
has long been appreciated that bacteria must possess robust mechanisms to control when and where PG
hydrolases are activated. However, the molecular details underlying these regulatory processes are lacking.
Research in my laboratory focuses on uncovering and characterizing regulatory systems controlling PG
hydrolase activity during normal growth, and how antibiotics short-circuit this regulation to trigger cell lysis. Using
the human respiratory pathogen Streptococcus pneumoniae as a model organism, we found that PG hydrolases
are controlled by two cell envelope polymers known as teichoic acids (TAs): membrane-linked lipoteichoic acids
(LTAs) and cell wall-anchored teichoic acids (WTAs). Characterization of novel enzymes involved in TA
synthesis and remodeling revealed that cell-wall targeting antibiotics hyperactivate PG hydrolases by disrupting
the normal mechanisms that balance the levels of WTAs and LTAs in the cell envelope. Current studies in my
laboratory indicate that the levels of TAs are controlled by a complex regulatory network involving post-
translational modifications and targeted proteolysis. We also discovered that the modulation of the TA levels in
the cell envelope has significant impacts on cell morphology, growth, and tolerance to antibiotics. However, many
aspects of this regulation and synthesis and remodeling pathways remain unknown. Therefore, the goals of this
proposal are to (i) identify signals and pathways that modulate LTA biogenesis and characterize how antibiotics
subvert them; (ii) determine the physiological roles and regulation of a widely-conserved protease and
characterize how antibiotics hyperactivate its activity to disrupt LTA biogenesis; (iii) characterize the regulation
of a novel WTA remodeling enzyme, and uncover how S. pneumoniae uses WTA levels to control lysis and
promote growth. The results generated by this research will provide fundamental insights into broadly relevant
principles for envelope assembly and maintenance in S. pneumoniae and related bacteria. S. pneumoniae has
become an alarming multidrug-resistant health threat. Therefore, novel antibiotics that target S. pneumoniae are
critically needed. The studies proposed here will reveal general mechanisms by which bacteria remodel their
envelopes to survive antibiotic exposure and uncover new targets for therapeutic intervention.

Public health relevance
Project Narrative This application seeks to discover and characterize the molecular mechanisms controlling the synthesis and remodeling of bacterial cell envelope polymers called teichoic acids and define how this regulation is corrupted by antibiotics to trigger cell lysis using the pathogen Streptococcus pneumoniae as a model system. The research proposed here will yield a mechanistic understanding of how these cell envelope biogenesis and remodeling systems affect bacterial physiology and uncover new ways to inhibit these processes for the development of therapeutics against infections caused by S. pneumoniae and related pathogens. Since many virulence determinants are embedded within or secreted across the cell envelope, our results will also impact pathogenesis research.